Fibroblast Heterogeneity in Pancreatic Cancer

ABSTRACT
Pancreatic ductal adenocarcinoma (PDA) is characterized by an extensive desmoplastic stroma that represents
a major challenge for its effective treatment and improved survival of patients. We seek to define the composition
and roles of cancer-associated fibroblasts (CAFs), the most abundant cell population in the PDA stroma, as a
potential avenue for the development of new therapeutic strategies. Although CAFs have been historically
considered tumor-promoting components, their ablation in pre-clinical and clinical studies have led to mixed
outcomes, indicating the poorly understood complexity of CAFs. To investigate CAF biology, we previously
established a pancreatic tumor organoid/fibroblast co-culture model. In addition, we performed single cell RNA-
sequencing (scRNA-seq) of murine and human PDA specimens to characterize CAF composition at single-cell
resolution. These analyses have revealed that fibroblasts are heterogeneous and comprised of at least three
distinct subtypes with unique transcriptional and functional features. More so, this heterogeneity emphasizes the
need to design therapies that selectively target the tumor-promoting CAF populations. Although our work has
started to reveal the complex heterogeneity of fibroblasts in primary or metastatic PDA tissues, iterative
developments in scRNA-seq and analysis methods have revealed four additional CAF subtypes in primary and
metastatic PDA. To comprehensively define the CAF repertoire in primary and metastatic PDA, we will
systematically differentiate CAF subtypes and their regulatory elements using scRNA-seq, scATAC-seq,
machine-learning computational methods, and in situ tissue analytic methods that detect RNA and protein
species, such as imaging mass cytometry (Aim 1). We hypothesize that a deeper understanding of the dynamic
CAF states that occurs in primary and metastatic PDA will guide the selection of specific therapeutic regimens.
To complement this analysis, we will identify new CAF subtypes and study their dynamics in a novel murine
model with a reversible mutant Kras allele (Aim 2). Furthermore, we will study CAF-activating pathways by
investigating several genes implicated in stromal activation that were revealed using our recently developed
intraductal transplantation model of PDA (Aim 2). These new mediators appear to have roles in PDA progression,
immunosuppression, and stromal activation, and may represent new PDA therapeutic targets. Finally, we have
demonstrated different immunomodulatory functions of distinct CAF subtypes. We will test combinatorial
strategies to target distinct CAF subtypes in the PDA microenvironment, and study the effect of these strategies
on tumor progression in a murine PDA model (Aim 3). In addition, we will assess the role of macrophage-CAF
crosstalk in promoting and maintaining CAF identify. Overall, this project will clarify the diversity of PDA CAFs
and the role of cancer cells in regulating CAF subtypes. Our results will provide new avenues for CAF-targeting
that we intend to translate towards improved therapies for patients afflicted by this lethal disease.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is a deadly disease, in part, because the cancer cells are able to recruit non-cancerous cells called “fibroblasts” that in turn can help the cancer cells grow and evade therapies. The purpose of this study is to better understand how these non-cancerous fibroblast cells change during the development of pancreatic cancer, how different types of noncancerous cells contribute to tumor growth, and how we can develop new drugs to prevent these cells from aiding the cancer cells. This work will identify new ways to block the cancer- promoting, fibroblast cells, which could lead to new treatments for patients affected by pancreatic cancer.